Glutathione, Brain Metabolism and Inflammation in Alzheimer's Disease

Alzheimer's disease (AD) is associated with significant, progressive cognitive decline, unimpeded by FDA-approved drugs.
Key defects in mitochondrial fuel metabolism could contribute to cognitive decline in AD. The primary mitochondrial fuel
of choice for the brain in the fasted (and fed) state is glucose. Conversely, fasted mitochondrial fuel of choice for the rest of
the body is fatty-acids. Hence fuel oxidation is partitioned between glucose for the brain, and fatty-acids for the rest of the
body. Aging is a major risk factor for AD. Mitochondrial fatty-acid oxidation (MFO) is impaired in aging, and brain glucose
uptake is decreased in patients with AD, but underlying mechanisms are not well understood. Aging and mitochondrial
dysfunction are also associated with insulin resistance (a hallmark of AD), which limits brain glucose-uptake. AD is also
strongly linked to neuroinflammation. Could mitochondrial dysfunction, insulin resistance and neuroinflammation be
mechanistically linked in patients with AD, and more importantly, could they be reversed to improve cognition? Ongoing
work from my lab has uncovered that Oxidative Stress (OxS) could be the unifying link. OxS is strongly linked to AD.
Glutathione (GSH, the most abundant intracellular antioxidant protein) combats OxS. GSH deficiency predisposes to OxS,
and is linked to AD. We reported that elevated OxS in older humans is caused by GSH deficiency due to diminished
synthesis because of decreased availability of its precursor amino-acids glycine and cysteine. Supplementing glycine and
cysteine (as N-acetylcysteine, a cysteine donor) orally as GlyNAC for 2w corrected deficiencies of glycine, cysteine and
GSH, and lowered OxS in older humans to levels in younger humans, reversed impaired MFO, and lowered insulin
resistance by 40%. Since aging is a major risk factor for AD, we studied cognition in 8 older humans before and after
receiving GlyNAC for 24w and after stopping GlyNAC for 12w, and outcomes compared to 8 unsupplemented young,
healthy controls: older humans had impaired cognition, elevated OxS, lower MFO, higher mitochondrial glucose oxidation
(MGO), higher insulin resistance and inflammation. GlyNAC supplementation for 24w significantly improved cognition
and whole-body mitochondrial fuel oxidation, and lowered OxS, insulin resistance, and inflammation. After stopping
GlyNAC, all benefits began to recede. We studied 98-week old C57BL/6J mice and found that compared to young 20-week
old mice, they had cognitive decline, and severely impaired ability of mitochondrial complexes I and II to oxidize glucose
substrates pyruvate, glutamate and succinate, and elevated inflammation (TSPO expression) GlyNAC supplementation for
8-weeks corrected these defects and improved cognition. Collectively, these data suggest that abnormalities in brain MGO,
inflammation, OxS, and insulin resistance combine to cause cognitive decline, and GlyNAC (via GSH) can correct these
defects to improve cognition. However, these defects and their response to GlyNAC have not been studied in patients with
AD. The goal of this proposal is to study these defects in patients with AD, and test whether supplementing GlyNAC can
improve cognition in AD by correcting GSH deficiency, poor brain glucose uptake and brain inflammation.

Public health relevance
Patients with Alzheimer's disease (AD) develop cognitive decline and dementia, and this is linked to impaired ability of the brain to use glucose as fuel, brain irritation known as inflammation and oxidative stress, and we do not know why these happen. Our group found that a deficiency of a protein called Glutathione could play a role, and we found that supplementing the diets of elderly humans who have early loss of cognition with protein building blocks called glycine and N-acetylcysteine (GlyNAC) corrects Glutathione deficiency and improves their cognitive function, glucose metabolism, inflammation and oxidative stress, and when these supplements are stopped the benefits begin to decline. Because it is not known whether GlyNAC can improve similar defects in patients with AD, this study will find out if supplementing GlyNAC for 24-weeks in patients with AD can improve cognition and these associated defects, compared to patients with AD who do not receive GlyNAC.